2022 Bacterial Cell Surfaces GRC/GRS

ABSTRACT
This proposal seeks support for the 24th Gordon Research Conference (GRC) on Bacterial Cell Surfaces, the
only meeting that connects cutting-edge research on cell envelope biology to the medically important
downstream consequences of the bacterial cell surface. The 2022 meeting will be held June 26-July 1, 2022 at
Mount Snow Resort, West Dover, VT and will have an associated Gordon Research Seminar (GRS). The
meeting will cover topics that are of great interest to the biomedical community, especially in the current climate
of the increased threat of multi-drug resistant pathogens, the need for novel vaccines, and the influence of the
microbiome on human health. This GRC presents a diverse program in topics, model systems, and approaches
combining biochemistry, molecular genetics, structural biology, cell biology, biophysics, imaging and modeling.
There will be 9 sessions encompassing: (1) Exploring the Bacterial Cell Envelope; (2) Modifying the Bacterial
Surface; (3) Cell Division and Morphogenesis; (4) Stress Responses and Signaling Across the Cell Envelope;
(5) Mechanisms of Surface Recognition; (6) Transport through the Envelope; (7) Type VI and Type VII Secretion;
(8) How the Surface Influences Bacterial Communities; and (9) Biophysical Methods to Improve Antimicrobial
Therapies. The conference will focus on the latest, largely unpublished, and most exciting research on the
assembly and function of the bacterial cell surface. We have selected a group of leading scientists, including a
number of rising stars, and have closely considered seniority, gender, and diversity. To enhance the 2022
meeting, we have included roundtable discussions for junior scientists to engage with leaders of the field, the
GRC Power Hour to examine issues of inclusion and diversity, and additional travel awards to support minority
trainees. Additionally, we have further integrated the highly successful GRS for postdocs and graduate students
with the GRC. Participants of the GRS will select 2 talks from the GRS for presentation at the GRC and the GRS
co-chairs will present a summary of their meeting at the GRC opening. The traditional format of GRC meetings,
with programmed discussion sessions and opportunities for informal gatherings in the afternoons and evenings,
conveys a collegial atmosphere where interactions between attendees of all career stages are easily attained.
The topics of this multifaceted conference are of practical interest to the biomedical community, and the mission
of the NIH as it provides a platform for nucleating approaches to antibacterial strategies, vaccine development,
and study of host-microbe interactions.

Public health relevance
NARRATIVE The bacterial cell surface and biological processes of the envelope are critical to interactions of bacteria with each other and with the host. Surface and envelope processes influence the development of a healthy or disease promoting microbiota, mechanisms of antibacterial resistance, and bacterial pathogenesis. This conference brings together prominent and junior scientists to present the latest, cutting-edge research focused on the assembly and function of the bacterial surface, and how it relates to human health and disease.